The San Diego Regional Network Award for Kidney, Urologic, and Hematologic Research Training

OVERALL – PROJECT SUMMARY
This is a resubmission application for a new U2C/TL1, requesting support to promote high quality,
collaborative training in kidney, urology, and hematology research in the San Diego area. The application
represents a collaborative submission from the 3 major academic research institutions in the region inducing
UC San Diego (UCSD), The Scripps Research Foundation (TSRI), and San Diego State University. This
U2C/TL1 is designed to address the KUH mission areas, foster collaboration, and comprehensively address
training and mentoring across the continuum of career stages.
The San Diego U2C/TL1 builds upon the outstanding local resources and prior experience in pre- and post-
doctoral research training. It builds upon recent successes fostering nephrology training through a T32 (2016-
2021), and recent post-doc successes at TSRI and SDSU. TSRI in an outstanding research institute, with 2 of
the last 5 years’ Nobel Prizes in Chemistry, and is ranked in the top 10 for graduate training in biology and
chemistry and has an outstanding track record for recruiting and training both pre- and post-doctoral scholars.
SDSU offers a pool of over 30,000 undergraduate 3000 graduate students annually, with nearly 30% from
under-represented minority (URM) backgrounds, and is a federally designated Hispanic serving institutions. It
already has multiple joint programs with UCSD and is heavily invested in expanding pre- and post-doctoral
training. UCSD is also a top 10 graduate program, offers over 6000 graduate students annually, and the only
academic medical school in the region, providing a link to outstanding Departments and Divisions of
Nephrology, Urology, Hematology, and other affiliated programs. With only 5 years of support, UCSD
Nephrology’s T32 graduated 66% of its post-doc scholars with K-series or VA Career Development Awards
(CDAs) – all of these individuals also secured faculty positions at research intensive institutions. Similar
parallel successes occurred at TSRI and SDSU. These scholars came from a wide variety of disciplines but all
focused on KUH research careers, demonstrating our abilities to guide young scientists to KUH research
pathways. The grant is structured around 5 core pillars learned and carried forward as best practices from our
recent training experiences, as we now expand our focus to hematology and urology, and across the career
continuum.
With highly successful and engaged TL1 faculty, pilot grants to foster collaboration across KUH disciplines,
and to drive young scientists into KUH research careers, a vibrant network, substantial and well developed
programs for professional development, and robust infrastructure and administrative support, this U2C/TL1 is
uniquely positioned to train outstanding scientists in KUH research topics, and supply the workforce with
innovative scientists making groundbreaking discoveries in KUH throughout their careers.

Public health relevance
OVERALL - PROJECT NARRATIVE Kidney, urology, and hematology all represent areas in medicine with critical needs for additional outstanding investigators to fuel high impact discoveries and treatments in future years. Research training in these areas requires a dedicated community with diverse research expertise, committed mentors who are also outstanding scientists, and training in multiple facets of research conduct. This U2C/TL1 aims to support a network of investigators in San Diego to provide outstanding training and mentorship in kidney, urology, and hematology research.